Ultrahigh-resolution Functional MRI of the Human Brain at 10.5 Tesla

MRI is the most advanced and the most used tool in our armamentarium to study the human brain. However,
highest possible resolution achievable with existing methods falls short of goals set for the next generation
Human Connectome Project (HCP) or the BRAIN Initiative that calls for the capability to study the organizing
principles of the human cortex at the mesoscopic or sub-mesoscopic scale. Our long-term goal is to advance
ultrahigh field (UHF) MRI through innovative technical developments applied at the highest possible magnetic
field available for human studies. The overall objective of this study is to develop a new suite of MRI tools that,
when synergistically combined with the unique UHF of 10.5 Tesla (10.5T) and optimized instrumentation (RF
coils and gradients), will enable us to acquire high-quality, whole- and partial-brain functional MRI (fMRI) at
unparalleled spatiotemporal resolutions, ushering in the next generation HCP and approaching the ambitious
resolution target (i.e., 0.01-µL voxel volumes) set in the strategic plan developed by the second BRAIN Initiative
Working Group. The overall objective will be accomplished by pursuing four specific aims: Under aim 1, we will
develop and optimize new high-channel-count transmit and receive RF arrays to leverage SNR gains available
at 10.5T while enabling RF parallel transmission (pTx) for flip angle homogenization and SAR reduction. For aim
2, we will devise two new pTx pulse design frameworks that incorporate RF-power-related constraints for water-
selective excitation tailored for whole-brain scan without the need for additional fat saturation, and a fat-selective
saturation and a water-selective excitation, suitable for partial-brain scan of a single imaging slab. Under aim 3,
we will develop i) a comprehensive pTx-enabled 3D GRE EPI sequence for rapid high-quality high-resolution
whole-brain and partial-brain scans, all with joint motion and field correction, ii) a computational toolkit enabling
real-time motion detection, background field measurement, and GIRF-based field dynamics determination using
NMR field probes, and iii) a tailored image reconstruction for producing motion- and field-corrected images based
on field dynamics and motion detection. The results will be compared to those obtained with our long-standing
and extensively used 2D simultaneous multi-slice EPI sequence. For aim 4, we will develop and demonstrate
brain fMRI at spatiotemporal resolutions that are much higher than what is possible with existing methods. The
research proposed in this application is significant because it is expected to have a broad positive impact on
various fields including ultrahigh-field MRI, RF hardware, high-resolution fMRI, parallel transmission, data
acquisition, image reconstruction, and neuroscience. The proposed research is innovative because it represents
a new and substantive departure from the existing approaches by shifting focus to developing a synergy of
various technical innovations that can help realize the full potential of 10.5T, enabling ultrahigh-resolution fMRI
and increasing our ability to study brain function at the mesoscopic scale.

Public health relevance
The proposed research is relevant to public health because it aims to develop a new suite of MRI tools (including leading-edge hardware and software) that can be synergistically combined with the unique ultrahigh field of 10.5 Tesla and high-performance head gradients to enable rapid acquisition of high-quality functional MRI at unprecedented spatiotemporal resolutions, thereby increasing our ability to study human brain function in health and disease at the mesoscopic scale. Once such a suite of MRI tools has been developed, there will be a potential for opening new research horizons, particularly in RF coil design, parallel transmission, data acquisition, image reconstruction, functional brain mapping, and their application to study the human brain. Thus, the proposed research is relevant to the NIBIB’s mission, which is to improve health by leading the development and accelerating the application of biomedical technologies.